OCTREOTIDE CONJUGATES FOR DIAGNOSIS AND THERAPY

One of the goals of this proposed research is to increase the number of radioligands available for the labeling with the positron emitting isotope Ga-68 and the readily available gamma-emmiter in-111. Specifically, efforts will focus on the synthesis of a new diaminoethane dithiol bifunctional chelate that has been found to have the highest stability for Ga(III) and in(III). This chelate be conjugated to a somatostatin analogue, octreotide. Certain cancerous tumors contain a large number of somatostatin receptors, therefore octreotide-radiometal conjugates can be used to diagnose and treat certain cancers by binding to somatostatin receptor and including a growth inhibitory effect in these tissues. The ability of this diaminoethane dithiol-octreotide- radiometal conjugate to bind somatostatin receptors will be determined using AtT-20 mouse pituitary carcinoma cells. The biodistribution and metabolism the conjugate will be determined using normal Sprague-Dawley rate. Biodistribution studies will be accomplished by extracting the activity from the various organs and counting each sample using a gamma- counter. The metabolism of the complex will be analyzed using HPLC and radio-TLC. The second goal of this proposal is to evaluate radiolabeled octreotide as a radiotherapeutic agent using tumor-bearing rats. This will involve new production techniques for 64Cu at Washington University, the preparation of 64Cu-chelate-octreotide and the manipulation of a tumor-bearing rat model for evaluation of therapeutic efficacy of 64Cu. Tumor growth inhibition will be evaluated by determining the % survival of animals per week post-treatment. At the time of their death the rats will be dissected and the tumors weighed.